Kyaterekera Project: A Combination Intervention Addressing Sexual Risk-Taking Behaviors Among Vulnerable Women in Uganda

Female Sex Workers (FSWs) in sub-Saharan Africa (SSA) have been identified as a high-risk group for the
spread of HIV/AIDS, with those in poor areas and “HIV hotspots” being especially vulnerable. Research has
shown that the primary reason poor women engage in commercial sex work is financial instability. Given these
challenges, poor women require support over and above HIV prevention education. We propose to test the
impact of adding economic empowerment (EE) components to traditional HIV risk reduction (HIVRR) to reduce
new incidence of sexually transmitted infections (STIs) and of HIV among FSWs in Rakai and Masaka districts
in Uganda. Guided by social-cognitive and asset theories, the study provides an avenue for FSWs to explore
alternative means of safe and sustainable income to replace sex work. The study is informed by a previously
tested microfinance (MF) intervention for FSWs in Mongolia, a pilot study conducted with FSWs in Masaka and
Rakai, surveillance studies by RHSP, and EE interventions among AIDS-affected families in Uganda. Using a
cluster-design we will randomly assign 990 FSWs from 33 matched town centers to one of three study arms (11
town centers in each condition): (1) A control arm comprising of treatment as usual (TAU) for FSWs in the study
area bolstered with 4 evidence-based sessions of HIVRR provided by local providers (n=330); or (2) A
treatment arm including TAU, 4 sessions of HIVRR, combined with receipt of a matched savings account
(HIVRR+S) to be used on short- and/or long-term consumption and skills development as per participants’ own
discretion (n=330); or (3) A treatment arm including TAU, 4 sessions of HIVRR, combined with a matched
savings account to be used on short-term and/or long term consumption and skills development as per a
participant’s own discretion plus 6 sessions of financial literacy and 8 mentoring sessions for supportive
transition to alternative income options (HIVRR+S+FLM) (n=330). This RCT study’s aims are to: Aim1:
Examine the impact of a financial savings-led MF intervention using HIVRR+S and HIVRR+S+FLM on HIV
biological and behavioral outcomes in FSWs (Primary outcomes: women’s cumulative incidence of biologically-
confirmed STIs and reported number and proportion of unprotected sexual acts with regular and paying
partners; Secondary outcomes: women’s rate of new HIV cases, proportion of monthly income from sex and non-
sex work, reported number and proportion on preventive behaviors, and for HIV+ women only, viral load as a marker
of ART adherence). Aim 2: Examine intervention mediation and effect modification to assess whether primary
outcomes are mediated/moderated by participant characteristics; whether key theory-driven variables and
Behavioral Economics measures mediate/moderate intervention outcomes. Aim 3: Qualitatively and
quantitatively examine implementation in each study condition; and Aim 4: Assess the cost and cost-effectiveness
of the HIVRR+S and HIVRR+S+FLM intervention compared with traditional HIVRR in terms of cumulative number of
STI and HIV cases averted over the 24-month period.

Public health relevance
Project Narrative/Public Health Relevance Statement The proposed study will be the first to provide crucial evidence on the efficacy of a combination of structural economic empowerment components and HIV prevention intervention on reductions of new STIs and HIV infections for women engaged in commercial sex work in Uganda, while also illuminating the unique barriers to and facilitators of implementation for purposes of sustainability and future scale-up. By fostering financial stability and increasing employability and access to income via marketable skills, the proposed study addresses the social and structural causes that, in this case, drive financially insecure women to engage in high risk sexual transmission behaviors. This study has significant implications for HIV prevention, care and treatment programming, which is a public health priority.